Intrinsic CRF signaling within the lateral habenula

Abstract
Corticotropin releasing factor (CRF) released from the hypothalamus is known for its role as the
neuroendocrine stress mediator by regulating the hypothalamic-pituitary-adrenal (HPA) axis. However,
CRF signaling in extrahypothalamic brain regions also plays a key role in regulation of positive and
negative reinforcement of motivated behaviors in response to stressors through distinct CRF neural
circuits. Moreover, sex biases in CRF signaling may underlie female vulnerability to anxiety and
depression. Recently, we showed that the lateral ahebnula (LHb), an anti-reward brain region also
implicated in anxiety and depression, is a highly CRF-responsive brain region although the source of this
extrahypothalamic CRF neurotransmission to the LHb and its behavioral relevance in both sexes are still
unknown. Therefore, in this R21 grant proposal, we aim to explore the contribution of a newly identified
LHb neuronal subpopulation that expresses CRF (LHbCRF neurons) and provides a local inhibitory circuit
within the LHb in regulation of LHb activity and related anxiety-related behaviors in a sex- and circuit-
specific manner. Our specific aims are to identify the role of LHbCRF→LHb circuit in anxiety-related
behaviors and in CRF-dependent regulation of LHb. Our innovative experimental approach utilizing
mouse genetics, viral-based strategies, ex vivo optogenetics with electrophysiology, chemogenetics,
GCaMP calcium imaging, and behavior in female and male mice will enable us to uncover novel roles for
CRF in circuit-specific regulation of LHb function and LHb-related anxiety behaviors with implications
in stress-related disorders and female susceptibility to stress.

Public health relevance
Project Narrative The goal of this pre-clinical proposed study is to identify the role of corticotrophin releasing factor (CRF)-expressing neurons within the lateral habenula (LHb) in regulation of LHb activity and related behavioral anxiety in male and female mice.